Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Scientific Meetings and Publication

The Division of Translational Toxicology (DTT) requires support for a number of scientific meetings with a broad focus on topics to support programmatic activities. These meetings help bring together experts in the field for discussion and review of project and program concepts. DTT utilizes these meetings as a scientific sounding board and to continuously improve scientific research strategies. Also under this project, several complex scientific reports require support for publication of these lengthy and complicated documents. Publication efforts include coordination of submission of reports to the DTT website as well as to NCBI Bookshelf. There are a number of activities to support templates for report development that must be compatible with .doc to XML and XML to HTML conversion software that are maintained under this project. Keywords: publication, meeting support.